SNEPT and SPLIT implementation of a QoL measure in pediatric transplant recipients

This collaborative effort is proposed by two networks that seek to integrate patient priorities into
pediatric transplant care: the Starzl Network for Excellence in Pediatric Transplantation –
SNEPT and the Society of Pediatric Liver Transplantation – SPLIT. Our networks will enable
implementation, evaluation, and improvement in a “stepwise” fashion: SNEPT, a collaboration of
7 leading centers, will implement a patient-reported outcome measure (PROM) which measures
quality of life (Pediatric Liver Transplant Quality of Life questionnaire, PeLTQL), evaluate
feasibility, and identify needed improvements in the first phase. SPLIT, with 40 centers, will host
the second implementation phase.
To enable PeLTQL integration into practice, we will use an innovative health-IT platform
(RealTime Clinic©; RTC), developed by the father of a transplant recipient to improve family
engagement in care. The platform is a smartphone application and a web-based interface.
Parent and child will complete the PeLTQL before the visit. RTC will report to the clinical team
an individual score for parent and child, as well as a “discrepancy score” (the difference
between parent and child scores). Clinicians will act on the information as needed.
In the first phase of implementation, we will customize RTC for use in SNEPT centers, collect
information on usability and impact on patient outcomes (adherence to medications and quality
of life), and modify the tool as appropriate based on the findings and feedback. We will then
move into a broader implementation through all SPLIT sites. Our final goal is at least 80%
implementation in SPLIT, which, if achieved, would mean broad implementation in transplant
centers across North America and beyond.
This study is expected to lead to actionable information about integration of quality of life
measures into post-transplant care in particular, and pediatric ambulatory care more generally.

Public health relevance
Two networks of pediatric liver transplant centers, the Starzl Network for Excellence in Pediatric Transplantation, which encompasses 7 centers in North America, and the Society of Pediatric Liver Transplantation (40 centers) propose to evaluate the integration of a patient reported outcome (the Pediatric Liver Transplant Quality of Life questionnaire) into clinical practice, via an innovative web-enabled platform / application. The application, RealTime Clinic ©, enables a bidirectional connection between physicians and families. This innovative collaborative investigation will help understand how new health Information Technology strategies can increase the utilization of patient reported outcomes and contribute to improved patient-centered health outcomes and quality of care.